SUPPOSITORIES FOR RAPID ANTI-EPILEPTIC DIAZEPAM DELIVERY

The Contractor shall prepare experimental suppositories, test them in rabbits, make indicated modifications, and demonstrate that these suppositories have practical for rapid treatment of convulsions in human beings.